Administrative Core

PROJECT SUMMARY (See instructions): The Administrative Core (Core A) will provide coordination of scientific activities for the 3 projects and 3 cores. It will also facilitate daily operations and longer term planning for the individual and overall scientific program. Statistical consultation will also be available from the Core via Chengjie Xiong, a biostatistician. Core A has 2 aims. Specific Aim 1. To facilitate communication, data sharing, and organize meefings between project leaders and our internal and external advisory boards. Dr. Xiong, as biostatistician, will provide statistical consultation for the projects and cores. Specific Aim 2: To assist in sharing PPG generated research with the general scientific and lay community as well as within and among PPG investigators.

Public health relevance
RELEVANCE (See instructions): Alzheimer's disease (AD) is the most common cause of dementia. There is no effective treatment that slows the progression of the disease. This core will provide an organizational structure for our efforts to better understand the relationship between cellular communication in the brain (synaptic activity) and the development of Alzheimer's disease.